Mitochondrial Derived Peptides in Chronic Obstructive Pulmonary Disease

Abstract
Chronic obstructive pulmonary disease (COPD) is characterized by accelerated lung aging and
tissue destruction. COPD affects approximately 16 million adults in the US with a prevalence of
6% and is the 6th leading cause of death. In COPD, the lungs develop chronic inflammation,
abnormal epithelial repair and irreversible alveolar destruction called emphysema. Major risk
factors for COPD include cigarette smoke (CS) exposure, air pollution and genetics, leading to
millions of affected individuals worldwide with few effective treatments, which fail to reverse the
disease course. COPD pathogenesis involves dysfunctional mitochondria that contribute to
abnormal lung remodeling when confronted with an injury. Mitochondria are key metabolic
organelles that mediate overall cellular responses to stress and are signaling hubs through
mitochondrial-derived peptides (MDPs). Several MDPs that normally have protective roles have
been shown to be depleted in neurological disease. We seek to better understand which MDPs
are dysregulated in COPD and how they contribute to mechanisms of lung aging to develop
therapies that will halt or reverse COPD development. We will utilize the NHLBI BioLINCC
repository to test plasma and lung tissue for MDPs to characterize pathogenic changes in
COPD across disease severity. We will combine experimental assays with novel bioinformatic
discovery tools, specifically mitochondria-wide association scans (MiWAS) and mitochondria-
wide interaction scans (MiWIS), to identify new MDPs related to COPD. Bioinformatic analyses
will be conducted using the NHLBI-funded COPDGene (Genetic Epidemiology of COPD) and
TOPMed SPIROMICS study cohorts. This research proposal will provide novel insights into
understanding accelerated lung aging in COPD by providing: 1) a comprehensive analysis of
MDPs and related SNPs in human COPD, 2) defining how these peptides correlate with clinical
factors such as lung function and 3) a scaffold for future studies defining the mechanistic and
therapeutic potential of MDPs to improve lung repair in COPD.

Public health relevance
This study will inform how mitochondrial derived peptides (MDPs) are dysregulated in chronic obstructive pulmonary disease (COPD) and understand how MDPs may contribute to lung aging and disease.